Bruker timsTOF fleX MALDI-2 for Biomedical Research at The Ohio State University

Abstract
A group of 15 investigators from 5 colleges/institutes and 12 departments at The Ohio State University and 1
investigator from Case Western Reserve University is requesting funds to permanently acquire a Bruker timsTOF
fleX MALDI-2 quadrupole time-of-flight mass spectrometer. This instrument was originally brought to the Ohio
State campus with a one-year, no obligation loan and has already resulted in thirteen publications from users.
This instrument empowers NIH-funded users in their tissue imaging studies with three new and needed
capabilities: 1) MALDI-2 post-ionization; 2) single-cell spatial resolution; and 3) trapped ion mobility (TIMS)
coupled with imaging. These three features are in high demand amongst NIH-funded OSU investigators and no
other instrument of this type is available on campus or within Ohio. While there are other imaging instruments
on campus, the balance of m/z resolution (at 60,000), scanning speed, imaging speed, and imaging resolution
makes the timsTOF fleX MALDI-2 a crucial, research-changing piece of technology for the growing number of
interested users at OSU. The instrument provides rapid detection and structural elucidation of a tissue landscape
in a non-targeted fashion with the capability of high-throughput MS and MSMS scanning with the use of TIMS
before quadrupole mass selection. The added feature of post-ionization with MALDI-2 increases signal intensity
for many small molecule metabolites (i.e., glycans, fatty acids, amino acids, and drug-metabolites). Likewise, the
diameter of the MALDI laser spot, needed for creating the pixelation of a tissue image, can be adjusted as low
as 5 µm, making the imaging spatial resolution the finest on the market and capable of imaging within a single
cell. Finally, the instrument can be readily switched between positive and negative modes and has a high m/z
dynamic range without the need for labeling, so researchers can overlap different molecular types to acquire
imaging overlays of protein and lipids or protein and drug metabolite interactions. This flexibility is critically
needed as the research programs of the 10 major users and the 6 minor users that will benefit from this
instrument are highly diverse, span two universities, and are funded by 16 NIH grants (spanning 5 NIH institutes:
NCI, NIGMS, NHLBI, NIA, NIBIB) as well as the NSF and the USDA. The requested instrument will be housed
in the OSU Mass Spectrometry and Proteomics Facility (MS&P) within the Campus Chemical Instrument Center
(CCIC), a unit of the OSU Office of Research that provides mass spectrometry access campus wide. Already
known for consistent research-driven instrumentation for LC-based proteomics and metabolomics, the CCIC
MS&P core is looking to provide the highest quality state-of-the-art instrumentation in imaging mass spectrometry
to match and facilitate both the omics already performed in the facility as well as the microscopy research
performed by NIH-funded researchers. The CCIC MS&P staff have the expertise and experience to support the
timsTOF fleX MALDI-2 and offer these services to a wide range of biomedical researchers at OSU and
throughout Ohio.

Public health relevance
Project Narrative This proposal requests the Bruker timsTOF fleX MALDI-2, a matrix-assisted laser desorption ionization (MALDI) imaging mass spectrometer with a trapped ion mobility (TIMS) cell. The instrument provides the highest quality imaging mass spectrometry (IMS) platform available, capable of high spatial resolution and high-throughput imaging of proteins and small molecules in single cells and biological tissues. The results produced by the requested platform will significantly enhance NIH-funded biomedical research at The Ohio State University and throughout Ohio.